Center for Advanced Multi-Omic Characterization of Cancer

PROJECT SUMMARY
The National Cancer Institute’s Clinical Proteomic Tumor Analysis Consortium (CPTAC) is a national effort to
accelerate the understanding of the molecular basis of cancer through the application of large-scale proteome
and genome analysis, or proteogenomics. Launched in 2011, CPTAC pioneered the integrated proteogenomic
analysis of colorectal, breast and ovarian cancer to reveal new insights into these cancer types, such as
identification of proteomic-centric subtypes, prioritization of driver mutations by correlative analysis of copy
number alterations and protein abundance, and understanding cancer-relevant pathways through post-
translational modifications.
In this project, CPTAC will collaborate with the NIH Common Fund Gabriella Miller Kids First Pediatric
Research Program (Kids First) to comprehensively characterize pediatric leukemia samples (such as T-cell
acute lymphoblastic leukemia, T-ALL, and acute myeloid leukemia, AML) using mass spectrometry-based
proteomics. This project will fully integrate proteogenomic information of such leukemia samples to capture and
replicate specific cancer phenotype, better understand the interconnection of cancer pathways, identify novel
protein targets for targeted therapies and immunotherapies, and to stimulate future pediatric cancer research
and precision oncology.
The PNNL PCC will perform comprehensive, integrated global proteome and phosphoproteome analyses of a
total of 272 pediatric leukemia samples provided by the Kids First collaborators in various forms (such as cell
pellets and surfaceome samples), using state-of-the-art liquid chromatography-tandem mass spectrometry
instrumentation, highly multiplexed isobaric mass-tag labeling (TMT 18-plex), and integrated sample
workflows. The resulting molecular data will become a community resource available at CAVATICA.

Public health relevance
PROJECT NARRATIVE Cancer is a disease that often originates in genomic abnormalities; however, these genome-level defects exert its functional significance at the level of proteins. Coordinating with the National Institute of Health Common Fund Kids First program, the Clinical Proteomic Tumor Analysis Consortium’s Proteome Characterization Center at the Pacific Northwest National Laboratory will comprehensively characterize the protein- and phosphorylation-level changes in cancer and healthy states by combing proteome- and genome-level information. This will help identify dysregulated signaling pathways for novel therapies for high-risk pediatric leukemias who do not respond well to current treatment options and have high rates of relapse.